Expanding the therapeutic window of chemoradiation through radiation-responsive nanoparticle drug depots

Certain cancers have remained difficult to control locally, despite progress in multimodal treatments that
combine X-ray radiation therapy (XRT), chemotherapy, and surgery. Although XRT can be delivered with ever-
increasing anatomical precision, most drugs used in conjunction with XRT exhibit rapid and non-specific
distribution throughout the body. High chemotherapy doses improve durable response rates in various
indications when combined with XRT, but severe and sometimes deadly off-target toxicities are frequent. Even
patients with durable remission can be left with debilitating side effects. Thus a major unmet challenge lies in
expanding the therapeutic window of chemoradiation to improve local disease control while mitigating
toxicities. We propose to address this issue by developing a nanoparticle-based strategy that uses XRT to
control the sustained and local release of chemotherapy payloads within irradiated tissue. Nanomaterials have
been extensively studied for their ability to enhance XRT effects. However, past strategies have often relied on
short-lived radical species operating over nanometer length-scales, leaving them susceptible to spatially
heterogeneous effects and variability from endogenous biochemical processes. To overcome this limitation, we
build on our past research in drug-loaded nanomedicines, radiation physics, and prodrug chemistry to develop
a Scintillating nanoparticle drug depot (SciDD) platform that operates by using nanoparticles to convert X-ray
energy into light that releases potent and tumor-penetrating cytotoxic drug payloads into irradiated tissue. In
preliminary studies, SciDD safely controls tumor progression in multiple mouse models of cancer while
mitigating systemic toxicities. Nonetheless, major knowledge gaps remain in understanding how such
radiation-activated drug delivery impacts the cascade of cellular and immunologic responses to XRT within the
tumor microenvironment, and in understanding how such an approach compares with traditional drug delivery
nanomedicines and radiosensitizers. We will therefore optimize SciDD as a platform for robust, sustained,
XRT-activatable drug delivery (Specific Aim 1), study the spatial and single-cell impact of XRT and SciDD on
the tumor microenvironment of orthotopic cancer models (Specific Aim 2), and test the ability to safely control
disease progression while mitigating systemic toxicity (Specific Aim 3). This project brings together new highly
multiplexed and in vivo imaging techniques to study the tumor microenvironment with molecular and spatial
detail, and will produce rich datasets comparing radiation-activatable drug delivery with traditional
radiosensitizing and drug-delivery nanoparticles. As a result, the project will advance radiation-responsive
nanomaterials for therapy and will shed light on how XRT affects the structure and enhanced permeability and
retention effects of the tumor microenvironment.

Public health relevance
Controlling local disease progression has remained a challenge for certain cancers, despite aggressive treatment with systemic chemotherapy and precise radiation therapy. To safely improve treatment eﬃcacy while minimizing systemic toxicities, this project will develop a new nanomaterial platform that uses local radiation therapy to control the sustained release of potent chemotherapy selectively within irradiated tumor tissue.